A precision medicine basis for estrogen therapy for advanced breast cancer

Project Summary: It remains unknown why some estrogen receptor alpha (ER)-positive breast cancers are
sensitive to estrogen therapy while others are resistant, and strategies for effectively utilizing estrogen therapy
are not well-established. The long-term goal of this line of investigation is to maximize the clinical potential of
endocrine therapies for the management of ER+ breast cancer. The overall objective of this project is to define
the mechanism that controls cell fate in ER+ breast cancer in response to the estrogen 17b-estradiol. The
central hypothesis is that basal estrogen-independent ER transcriptional activity caused by ER amplification,
overexpression, or mutation sensitizes breast cancer cells to the cytotoxic effects of 17b-estradiol/ER-induced
DNA damage. The rationale for this project is that definition of (i) the mechanism underlying therapeutic
response to 17b-estradiol and (ii) tumor features that dictate response to 17b-estradiol will provide a precision
medicine basis for its use and offer strategies to enhance response. The central hypothesis will be tested by
pursuing three specific aims: (1) Determine how 17b-estradiol/ER-induced DNA damage and response control
cell fate; (2) Determine how inhibition of the DNA damage response affects sensitivity to 17b-estradiol; (3)
Define the role of ER (ESR1) mutations in dictating breast cancer response to 17b-estradiol. In the first aim,
the kinetics and spatiotemporal relationship of 17b-estradiol/ER-induced transcriptional activity, DNA damage,
and response will be measured in genetically engineered and estrogen-independent ER+ breast cancer cells.
These studies will provide a mechanistic basis for the cytotoxic effects of 17b-estradiol. The second aim will
use cell lines and patient-derived xenografts for measurement of the effects of 17b-estradiol in the context of
pharmacological inhibition of poly(ADP-ribose) polymerases 1/2 (PARP) as well as homologous recombination
deficiency. These studies will offer treatment strategies to enhance response to 17b-estradiol. In the third aim,
engineered cells and ESR1-mutant patient-derived xenografts will be used for measurement of 17b-estradiol-
induced changes in cell fate, tumor growth, and ER transcriptional activity. These studies will provide
understanding of how ESR1 mutations shape cancer cell response to 17b-estradiol and provide a mechanistic
basis to inform its clinical use. The proposed research is innovative because it implicates ER-induced DNA
damage in the mechanism of cytotoxicity induced by 17b-estradiol therapy, enabling the development of
strategies that target the DNA damage response for advanced ER+ breast cancer. Based on our clinical trial
findings, this project will test the innovative concept that ER mutations sensitize ER+ breast cancer cells to
17b-estradiol. The proposed research is significant because it will reveal the root cause of 17b-estradiol-
induced cytotoxicity in ER+ breast cancer, as well as explain how cell adaptations convert 17b-estradiol from a
growth promoter to a growth suppressor. This research will also provide strong scientific rationale for clinical
testing of 17b-estradiol therapy in genetically identifiable patient subpopulations.

Public health relevance
Project Narrative: The proposed research is relevant to public health because it focuses on the development of estrogen-based therapeutic strategies for people with advanced ER+ breast cancer. Once the mechanism of anti-cancer action and strategies to enhance efficacy of estrogen therapy have been determined, there is potential for significant improvement in the management of this disease. Thus, the proposed research is relevant to the mission of NCI through the development of enhanced treatments that would decrease morbidity and mortality in patients with breast cancer.